T-type Calcium Channel Inhibitors and Alpha Lipoic Acid as Novel Therapies for Treating Pain Post-surgery

Pain-sensing sensory neurons of the dorsal root ganglion (DRG) and dorsal horn (DH) can become sensitized
(hyperexcitable) in response to the tissue injury. Because of insufficient knowledge about the mechanisms for
this sensitization, current treatment for postoperative pain has been limited to somewhat non-specific systemic
drugs (opioids) having significant side effects or potential for abuse. Recent studies in our laboratory have
established that CaV3.2 (T-type) calcium-channels voltage-gated calcium channels make a previously
unrecognized contribution to sensitization of pain responses by enhancing excitability of peripheral nociceptors
in the setting of surgically induced tissue injury. Despite the established role of CaV3.2 channels in the
pathogenesis of peripheral sensitization of pain responses, the role of T-channels in central (spinal) sensitization
of pain responses and its relationship with opioids is not well studied. We previously showed that the blockade
of CaV3.2 currents in nociceptive DRG neurons by an endogenous compound and dietary supplement α lipoic
acid (ALA) underlies its potent peripheral anti-nociceptive effects. Our new preliminary and recently published
data demonstrate that ALA displays excellent analgesia in a rat and mouse model of post-surgical pain resulting
from paw skin incisions. Thus, we propose that ALA may represent a safer class of analgesics having desirable
analgesic properties in post-operative period by targeting T-channels in pain pathway, as well as being able to
reduce the risk for the opioid addiction.
In Aim 1, we will study analgesic potency of ALA and its interactions with morphine using an established mouse
model of postoperative incisional pain.
In Aim 2, we will define the role of ALA in modulating synaptic transmission and neuronal excitability of
nociceptive dorsal horn (DH) neurons using optogenetics. Here, we will use a novel transgenic mouse line in
which CaV3.2 Cre mouse line will be crossed with channelrhodopsin-2 (Ch-R2) mouse line, an approach that
will allow us to optogenetically enhance the activity of CaV3.2-containing nociceptive afferents. These studies
will define the whole-cell neurophysiological effects of ALA in the major nociceptive pathway. We will also use
confocal microscopy in order to study cellular and subcellular localization of CaV3.2 channels in DH and DRG
neurons in mice with plantar surgical incision and after prolonged optogenetic stimulation that causes
sensitization of pain responses. The proposed work is innovative and medically significant because we anticipate
that our preclinical studies will identify novel therapies for perioperative pain that may greatly decrease the need
for narcotics and potential for drug abuse.

Public health relevance
Pain after peripheral tissue injuries resulting from skin incision is a major medical problem for veterans and members of the general population. Commonly employed treatments such as the use of opioids are particularly problematic due to many dangerous side effects, addiction and potential for drug abuse. Our published studies implicate CaV3.2 isoform of T-type calcium channels in sensitization of pain responses in post-surgery period. We will further investigate the role of these channels and their inhibitors like?α lipoic acid alone and in combination with morphine in the mechanisms of perioperative pain, using a clinically relevant rodent model of skin incision. At the conclusion of the project we expect to be able to translate our findings to clinical populations using the same agents optimized for use in the animal subjects. These studies may lead to better treatment of pain post-surgery and decrease the risk for opioid abuse in veteran population.